Genetic Engineering Technologies Shared Resource

PROJECT SUMMARY GENETIC ENGINEERING TECHNOLOGIES
The Genetic Engineering Technologies Shared Resource (GET) provides JAX Cancer Center (JAXCC)
members with all-inclusive access to the technical expertise, instrumentation, and centralized facilities necessary
to engineer and produce complex, precisely tunable, genetically engineered mouse models of cancer. Genetic
manipulation of the mouse genome and the production of novel genomic variants has been critical for evaluating
gene function in an organismal context. Unfortunately, many strains have been recalcitrant to genetic
engineering owing to their reproductive biology constraints and inefficiencies with the methods that induce the
gene modification. Thus, to produce next-generation mouse models, these limitations must be overcome by
combining optimal genetic background (i.e., strain) with the ability to engineer single, or multiple, genomic
variants with high efficiency in a cost-effective manner. Through the integration of molecular construct
development, cell biology, microinjection and viral vector expertise, GET is capable of taking a project from
conception to delivery of live mice with transient or germline-transmissible engineered mutations. On behalf of
the JAXCC members, GET performs the associated genetic engineering approaches, including allele design,
gene-editing reagent synthesis and QC, genotyping assay development, and mouse zygote or ES cell gene-
editing manipulation with modern targeted nuclease technology (CRISPR/Cas). The group has extensive
experience (>1000 CRISPR/Cas gene editing projects) and success generating genetically modified mice on
over 100 different inbred and specialty strains, and provides all the necessary husbandry to produce and validate
newly engineered mouse models. The design and production of high-titer viral vector preparations enable
JAXCC members to create somatic transgenesis mouse models that complement germline mutant models. Staff
within all components of GET provide consultation and experimental design support with gene engineering
specialists, as well as support for animal care and use, biosafety and biosecurity applications, training, and
provision of tested reagents and supplies for those investigators who choose to carry out aspects of the genetic
engineering and cell biology processes in their own laboratories. Our Specific Aims are to: 1) Provide a
comprehensive, precise genome engineering service capable of generating germline-transmissible alleles not
limited by the mouse strain of origin; 2) Provide comprehensive recombinant virus genome engineering tools for
introducing precise genetic modifications in mammalian cells; and 3) Provide molecular, cellular or embryological
tools for gene engineering or target validation processes for JAXCC members. Execution of these aims in a
centralized resource provides a cost effective, scalable, and precise genome engineering platform as well as the
technical and operational experience no single research laboratory could effectively create and maintain. This is
the value of GET for the JAXCC.